Longitudinal Assessment of Post-concussion Driving in Young Adults (LAPDYA)

PROJECT SUMMARY/ABSTRACT
Upwards of 3.8 million concussions occur annually in the United States. Only 44% of concussed individuals
reduce their driving at any point following injury despite emergent concerns over post-concussion driving
safety, documented driving impairment, and reports of feeling unsafe driving after a concussion. Most
concussed individuals who reduce their driving only do so for 24-48 hours following the injury. Driving is a
highly complicated activity that requires visual, motor, and cognitive skills, which are commonly impaired after
concussion. Concussed individuals cross the centerline more frequently within 48 hours of injury and present
with poorer vehicle control throughout the full symptom recovery. Yet, the time course of post-concussion
driving impairment has not been characterized. There is a critical need to 1) determine when concussed
individuals should return to driving and 2) identify the key concussion assessment predictors of readiness to
return to driving. In the absence of formal recommendations, impaired concussed drivers are at risk to
themselves and others on the road. The first specific aim is to compare simulated driving between concussed
individuals and non-concussed yoked matched controls across five longitudinal timepoints (pre-injury baseline,
day 2, day 4, asymptomatic, and unrestricted medical clearance) and daily naturalistic driving from day 2 to
day 9. Driving recommendations must be appropriate and necessitated by concussion impairments, since
excessively strict recommendations wrongfully strip concussed patients of their independence and may
dissuade individuals from seeking medical care. The second specific aim is to identify widely used
concussion assessment outcomes that predict simulated driving performance among concussed individuals
throughout concussion recovery. To address these aims, 100 concussed and 100 yoked matched control
young adult college athletes will complete a simulated driving assessment and a robust concussion
assessment battery at pre-injury baseline, day 2, day 4, asymptomatic, and unrestricted medical clearance.
Naturalistic driving (measured with in-car global positioning systems) will be captured from day 2 to day 9 (7
days total). This study will determine the acute and subacute time course of post-concussion driving
impairment and determine key predictors of post-concussion driving performance. Results from this innovative
approach will have a broad and positive impact that will improve the safety of both concussed individuals and
the general population, guide the practices of health professionals, inform the future work of researchers, and
substantiate the work of policy-makers by providing evidence-based recommendations for managing post-
concussion driving.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will (1) improve the safety of concussed individuals and the general population that use roadways, (2) guide the practices of health professionals, and (3) substantiate the work of policy-makers by providing strong evidence-based recommendations for managing post-concussion driving. This translational study is relevant to the mission of both the NIH and NINDS because it provides fundamental knowledge about how brain injury burdens concussed drivers, while also identifying which widely used clinical outcomes are associated with post-concussion driving impairment.